Functions of electrical synapses in inhibitory networks

PROJECT SUMMARY/ABSTRACT This project will investigate the functions of electrical synapses within inhibitory circuits of the mammalian forebrain. Electrical synapses are gap junctions that interconnect neurons, and they serve as rapid, bidirectional communication pathways. A considerable amount is known about the basic biophysical properties of mammalian electrical synapses, their locations, and their dependence on the gap junction protein connexin36 (Cx36). Gap junctions can strongly influence the timing, phase, synchrony, probability, and rate of action potentials in pairs and small groups of neurons, yet we still do not know how electrical synapses contribute to larger network functions. The complexity of forebrain circuits has long been an impediment, but powerful new genetic and optical tools can now be brought to bear on these issues. Remarkably, in the mature thalamus and neocortex electrical synapses occur almost exclusively between GABAergic neurons. These junctions are quite specific; they usually interconnect inhibitory neurons of the same subtype in the cortex, and excitatory cells in the mature forebrain rarely express them. This investigation will focus on the roles of electrical synapses that interconnect inhibitory neurons of the thalamus (specifically in the somatosensory thalamic reticular nucleus, TRN), and several subtypes of interneurons in the neocortex (barrel cortex). There are three specific aims. The first is to determine the roles of electrical synapses in thalamocortical network activity, specifically slow (delta, theta) and fast (gamma) network oscillations studied in vitro and in vivo. We will use electrophysiology, selective deletion of Cx36 from subtypes of cortical and thalamic inhibitory cells, and optogenetics to control specific neurons and axonal pathways. The second aim is to test the hypothesis that electrical synapses play an important role in the powerful feedforward inhibitory circuits activated by both thalamocortical and corticothalamic pathways. The third aim is to define the spatial and cell type-specific organization of gap junction-coupled networks in somatosensory segments of the TRN and neocortex. Inhibitory circuits are universal, and essential for all sensory, motor, and cognitive functions; electrical synapses are ubiquitous components of inhibitory circuits. Abnormalities of inhibition are implicated in a wide variety of neurological, psychiatric, and developmental disorders, and mutations in gap junction genes are associated with epilepsy and other neurological dysfunctions. Our investigation will help to clarify the relevance and functions of electrical synapses in inhibitory systems of the forebrain.

Public health relevance
PROJECT NARRATIVE Many nerve cells in the brain communicate with one another via specialized structures called electrical synapses. Mutations of genes critical for electrical synapses can cause epilepsy and other neurological disorders that involve abnormal types of neural rhythms and synchrony. This project will test the hypothesis that electrical synapses between inhibitory cells of the forebrain are important for generating and controlling brain rhythms and dynamics. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Inhibitory cells comprise a modest fraction of the neurons in the thalamus and neocortex (<25%), yet they are critically involved in all aspects of thalamocortical activity [56,85]. These GABAergic neurons are coupled by gap junction channels that act as electrical synapses, permitting intercellular ion flow [31,35,44]. Much has been learned about the basic properties of thalamic and cortical electrical synapses since we first demonstrated them [65,67,95]. Electrical synapses act as fast, bidirectional, modifiable, low-pass electrical filters. Electrical synapses in the mature forebrain are remarkably specific, mainly connecting inhibitory cells of similar subtypes but not excitatory cells [35,64]. The gap junction protein connexin36 (Cx36) is necessary for most mature connections [50,84,95]. There is a reasonably sound basis for understanding how electrical synapses influence the interactions of pairs and clusters of coupled cells [16,36,69,101,137,152]. Cortical and thalamic inhibitory neurons have been implicated in many neurological and psychiatric disorders, and mutations in neural gap junction genes cause a variety of abnormalities. Despite this progress, we still know very little about the roles of electrical synapses in the circuit-level functions of the thalamus and neocortex. The complexity of these circuits has been a challenge. Until recently it has been difficult to even identify the diverse types of coupled neurons in living systems, let alone to manipulate their physiology or gene expression. Furthermore, methods available to selectively regulate specific axons or network activity, and gap junctions themselves, have been limited. The tide is turning, however, and powerful new genetic, optical, and physiological tools can be brought to bear on these issues. The central goal of our investigation is to characterize the functions of electrical synapses between inhibitory neurons in cortical and thalamic network activity. We will apply selective methods to control connexin, opsin, and reporter gene expression in specific sets of neurons in the mouse somatosensory thalamocortical system, where network and pathway organization is reasonably well understood. We have previously used this system to study basic properties of gap junctions between inhibitory cells and, to some extent, their roles in network activity [31,44,66,67,93,95]. We have 3 aims: Aim 1. Electrical synapses and network activity: Determine the impact of gap junctions among distinct subtypes of cortical and thalamic inhibitory cells on network oscillations. We will test the hypothesis that gap junctions among the major classes of inhibitory cells have distinct roles in several types of spontaneous network activity. Our experiments will utilize a novel Cx36 conditional knockout mouse (with floxed Cx36 genes) [124] in combination with established Cre-driver mice targeted to major classes of GABAergic neurons in the thalamic reticular nucleus (TRN) and neocortex (parvalbumin-, somatostatin- and 5HT3aR-expressing interneurons). We will do both in vivo and in vitro experiments on four widely occurring and important types of network activity: 1) cortical gamma oscillations, 2) cortical theta oscillations, 3) cortical "Up states", and 4) thalamic spindle oscillations. We have established reliable in vitro models of each type of activity, allowing levels measurement and control not yet possible in vivo. Aim 2. Electrical synapses and feedforward inhibitory processing: Determine whether gap junctions among cortical and thalamic inhibitory cells strongly shape thalamocortical (TC) and corticothalamic (CT) evoked activity. We will test the hypothesis that electrical synapses influence feedforward inhibition by synchronizing evoked spiking among coupled inhibitory cells, sharpening the timing of feedforward inhibition, enhancing peak inhibitory potency, and thus shaping overall TC and CT evoked activity. The major targets of TC afferents are parvalbumin-expressing (layer 4) and 5HT3aR- expressing (layer 1) neocortical interneurons; CT afferents target inhibitory cells of the TRN. These cells are all extensively coupled by electrical synapses and strongly control responses of neighboring excitatory neurons with potent feedforward inhibitory synapses. We will conduct cell type-specific removal of Cx36 with the conditional knockout as a way to infer the effects of electrical synapses on TC and CT processing. Aim 3. Electrical synaptic microcircuits of TRN: Define the spatial and cell type-specific organization of gap junction networks in the somatosensory sector of the TRN. Knowledge of the patterns of electrically coupled networks is required to fully understand their functions. The organization of coupled networks in the TRN is very poorly understood. Our preliminary data suggest that coupled TRN networks are confined to regions within sectors and laminae, and that there are distinct subtypes of TRN neurons. We will test the hypothesis that gap junctional coupling respects boundaries between functionally distinct TRN subregions, and determine whether there are distinct subtypes of TRN cells defined by protein expression, intrinsic physiology, and electrical synapses.